ICP-TOF Mass Spectrometer for Ultrafast Elemental Mapping of Clinical and Preclinical Biospecimens

A. PROJECT SUMMARY
This shared instrument grant requests funding to acquire an inductively coupled plasma time-of-flight mass
spectrometer (icpTOF-MS) for ultrafast laser ablation (LA)-assisted multi-elemental mapping of high-value
clinical and preclinical biospecimens. The proposed icpTOF-MS (R-series, TOFWerk) will be sited at the
Boston University School of Medicine Center for Biometallomics (CBM), the only hospital/medical school-
based analytical core facility of its kind in the region. The icpTOF-MS enables >3000 mass resolution power
for multiplexed detection of all possible elements every 30 µs. Hyphenation to the CBM’s state-of-the-art LA
platform (300 Hz laser firing rate, <4 ns pulse width, spot size to 1 µm) will accelerate NIH-funded research
requiring ultrafast multi-elemental imaging mass spectrometry (MIMS) mapping at single-cell spatial resolution
in high-value organ, tissue, cell, and fluid biospecimens from humans, non-human primates, and small lab
animals (mice, rats) as well as experimental preparations, environmental samples, and other biomedically-
relevant specimens. The hyphenated LA-ICP-TOF-MS system will accelerate a core group of 11 major and 5
minor users who are funded by the NIH (NIA, NINDS, NHLBI, NIDDK) and other sponsors to conduct innovative
clinical and preclinical research on Alzheimer’s disease (AD), AD-related dementias (ADRDs, including tau
protein neurodegenerative diseases, such as chronic traumatic encephalopathy, CTE), vascular dementia,
stroke, traumatic brain injury, cardiovascular disease, chronic renal disease, cataracts, retinopathy, and heavy
metal toxicology linked to environmental and consumer product exposures (exposome research). The
proposed icpTOF-MS will also facilitate novel techniques (developed by CBM investigators) to detect, localize,
and quantitate microvascular dysfunction. The major user group includes NIH-funded investigators at Boston
University School of Medicine, affiliated national human tissue repositories (BU Alzheimer’s Disease Research
Center, BU-Concussion Legacy Foundation-VA Boston Brain Bank, Boston Chronic Kidney Disease Research
Center, and the Framingham Heart Study,) as well as major biomedical research institutions in the region
(Mass General Hospital, Harvard Medical School, The Jackson Laboratory), across the nation (Indiana
University, UCLA, Navy Medical Research, Lawrence Livermore National Laboratory), and around the globe
(Queen’s University Belfast). The proposed icpTOF-MS will greatly decrease MIMS scan time while increasing
spatial resolution, simultaneous acquisition of multi-element spectra, and analytical mapping throughput.
These enhanced analytical capabilities will not only accelerate cutting-edge NIH-funded research but also
enable novel 3D mapping reconstructions, multi-elemental colocalization analyses, and other data-intensive
applications enabled by this powerful analytical technology.

Public health relevance
B. PROJECT NARRATIVE This shared instrument grant requests funding to acquire an inductively coupled plasma time-of-flight mass spectrometer (icpTOF-MS) for ultrafast multi-elemental mapping of high-value clinical (human) and preclinical (lab animal) biospecimens. The instrument will be coupled to the CBM’s existing state-of-the-art laser ablation platform at the Boston University School of Medicine Center for Biometallomics (CBM), the only hospital/medical school-based bioanalytical core facility of its kind in the region. The proposed icpTOF-MS instrument will facilitate NIH-funded research targeting Alzheimer’s disease (AD), other neurodegenerative diseases, traumatic brain injury, cardiovascular disease, chronic renal disease, degenerative eye disease (cataracts, retinopathy), heavy metal toxicology, and gene-environment (exposome) interactions.